Buddhist Monks as Task-Shifting Providers of Depression Treatment in Viet Nam

PROJECT SUMMARY
Depression represents a substantial public health burden. Effective treatments for depression exist but in part
because of a scarcity of trained mental health professionals and stigma associated with “mental illness”, the
majority of depression patients do not receive treatment, particularly in LMIC. One approach to address these
issues is mental health task-shifting, the transfer of mental health services from highly trained mental health
professionals to non-mental health professionals or lay people receiving focused training in a particular mental
health program. Mindfulness-based (MB) interventions are a depression EBT, using activities to help people
become more aware of bodily sensations, feelings, and thoughts without automatically judging them, reducing
negative emotional reactivity that precipitates and exacerbates affective mental health problems. This R21
focuses on use of Vietnamese Buddhist monks as task-shifting providers of mindfulness-based intervention for
depression. MB interventions are derived from Buddhist meditation practices, developed and applied in a
secular manner. Use of Buddhist monks as task-shifting providers of MB interventions may be advantageous as
(1) meditation is a central part of Buddhist monks' training and although not mental health professionals,
monks have a solid background in underlying techniques being task-shifted; (2) pagoda-based treatment may
reduce treatment stigma. Project Specific Aims are: #1. Conduct a capacity development needs assessment
with approximately 68 stakeholders, using focus groups and Key Informant interviews, to prepare for this
project and more comprehensive future research; #2: Adapt Mindfulness-Based Stress Reduction (MBSR) for
task-shifting implementation by monks. Goals of this specific aim are (a) to adapt MBSR for monks (MBSR-
4M) to implement; (b) train the monks in MBSR-4M for implementation under Specific Aim #3; and (c)
through the process of collaborative sharing involved in the adaptation, increase our understanding more
generally of how our expanded team can most effectively collaborate together; #3: Conduct a Type 2 Hybrid
Implementation-Effectiveness evaluation of MBSR-4M. Primary goals are: (a) to gain experience collaborating
with the VN Buddhist system conducting implementation research, in order to (b) develop capacity for future
collaborative research in this and related areas; (c) identify cultural and other factors potentially influencing IS
domains for targeting in future research; and (d) obtain preliminary RCT data to assess the appropriateness
and success of our program adaptation. The MBSR-4M evaluation will be conducted in 16 Hanoi and Danang
pagoda with 160 participants (half in the treatment condition, half in control) with depression, recruited from
pagoda and the general community. #4: Capacity Development: A central function of these specific aims is to
develop capacity to support this research, by providing our team with the relevant knowledge, logistic
structures, and professional relationships necessary to move forward in these directions. In addition,
workshops targeting specific development areas identified in Specific Aim #1 also will be provided.

Public health relevance
Project Narrative – Public Health Relevance This project focuses on developing and evaluating a mindfulness-based intervention for treatment of depression, a form of mental illness. It thus is directly relevant to public health.